Vector and Host Contributions to the Regulation of E. chaffeensis Gene Expression

PROJECT SUMMARY Illnesses caused by rickettsiales of the genera Ehrlichia and Anaplasma are a growing human health concern in recent years and are the second leading cause of tick-borne infections in the USA and many parts of the world. They include human monocytic ehrlichiosis caused by Ehrlichia chaffeensis. Despite the sophisticated systems of defense in vertebrate and tick hosts, the rickettsiales evade the host clearance. E. chaffeensis in macrophages and tick cells differ significantly in expression of several outer membrane proteins and effector proteins secreted via its secretary pathways. Research results demonstrate that differential tick and vertebrate host cell-specific expression contributes to the varied host response and delayed clearance in a host. The central hypothesis of the previously funded project is that E. chaffeensis differentially regulates gene expression and that the host-specific gene expression is essential for its survival in vertebrate and tick cells. Progress from the previous funding cycle forms the strong foundation for this renewal application and to continue testing the above stated innovative hypothesis. Specific aims of this application are 1) to characterize E. chaffeensis RNA polymerase complex in support of understanding how vector and vertebrate host-specific differential gene expression is accomplished, 2) to evaluate the significance of host-specific differential expression by characterizing mutations in three genes identified as essential for E. chaffeensis in vivo growth, and 3) to perform mutational analysis and in vivo screening to identify genes essential for the E. chaffeensis pathogenesis.

Public health relevance
PROJECT NARRATIVE The results from this study will provide important information for understanding E. chaffeensis pathogenesis, gene regulation and how the rickettsiale in vertebrate and tick hosts respond to the loss of expression from differentially expressed genes. This study will also allow us to determine how the tick transmitted pathogen persists and will aid in identifying targets for controlling E. chaffeensis infections. __SpecificAimsTextDelimiter__ SPECIFIC AIMS: Illnesses caused by rickettsiales of the genera Ehrlichia and Anaplasma have been a growing health concern in recent years and are also the second leading cause of the tick-borne infections in the USA. They include human monocytic ehrlichiosis caused by Ehrlichia chaffeensis and human granulocytic ehrlichiosis and anaplasmosis resulting from E. ewingii and Anaplasma phagocytophilum infections, respectively. Recently, yet another new tick-borne pathogen, E. muris like agent, has been described as causing a disease in people. Despite the complex cellular environments of arthropods and vertebrates having sophisticated systems of defense, these rickettsiales evolved strategies to evade host clearance. For example, E. chaffeensis in macrophages and tick cells differ significantly in their morphology with distinct patterns of protein expression. The expression patterns include the differential expression from the multiple outer membrane proteins and effector proteins secreted via the pathogen's secretory pathways. For example, the p28-Omp multigene locus genes are differentially expressed; the p28-Omp gene 19 is highly expressed in macrophages, whereas in tick cells the expressed protein is predominantly the p28-Omp gene 14 product. Our studies also demonstrated that the differential expression in vertebrate and tick cells is conserved in other Ehrlichia species and that it contributes to the differential host response and delayed vertebrate host clearance. The central hypothesis of the funded NIH R01 project is that E. chaffeensis differentially regulates its gene expression in response to host cell environmental signals and that the host cell-specific gene expression is essential for pathogen's survival in vertebrate and tick cell environments. Specific aims of the funded project were to 1) establish in vitro transcription system for mapping Ehrlichia promoters, 2) map transcriptional machinery of two differentially expressed genes of the p28-Omp locus; genes 14 and 19, 3) evaluate the contributions of macrophage and tick cell environments for differential expression from genes 14 and 19, and 4) develop methods to evaluate knockout mutations to assess the biological relevance of host cell specific differential expression. We successfully accomplished the goals of aims 1 and 2. Goals of aim 3 are a work in progress and although much has been accomplished, some of the novel directions we took during the last funding period required additional expansion of experiments in this aim; it will be part of the renewal application (aim 1). Aim 4 was the most innovative and the most challenging because to date there are no methods described in the literature which aid in introducing foreign DNA and creating mutations in Ehrlichia species. We had to do a lot of ground work in achieving this goal, and indeed we have succeeded in accomplishing this challenging task. We now have protocols in place for creating both targeted and random mutations in E. chaffeensis. We have convincing evidence showing that stable gene inactivation mutations can be developed in E. chaffeensis; we developed mutations in several genomic locations of the organism, including within the coding regions of some genes. We also have presented the first evidence of identifying three genes essential for the pathogen's growth in vertebrate host. We accomplished this by utilizing an in vivo screening method which we established. These significant novel data, generated with support for the previous funding cycle, form the strong foundation for the goals we set for this competing renewal application having the following highly focused specific aims. The aims remain focused to continue testing our central hypothesis (outlined above). Specific Aims: 1) Characterize E. chaffeensis RNA polymerase complex in support of understanding the pathogen's host-specific differential gene expression 2) Evaluate the significance of host-specific differential expression by characterizing mutations in three genes identified as essential for E. chaffeensis in vivo growth 3) Perform mutational analysis and in vivo screening to identify additional genes essential for the E. chaffeensis pathogenesis in vertebrate and tick hosts We established all of the needed methods to accomplish the goals of the proposed project. We are the first and the only group in developing mutational methods. Likewise, we are the first and the only group in undertaking studies focused on defining the regulation of gene expression by Ehrlichia; all of the needed molecular tools for mapping the gene expression have been developed by us. We also carefully reevaluated and standardized additional research tools needed for advancing our understanding of the Ehrlichia pathogenesis; they include the establishment of infection studies in hosts involved in the transmission cycle of the pathogen, the white-tailed deer and its tick vector, A. americanum. Novel data in this revised submission include validating the use of a dog infection model. The infection studies in deer, dog and tick are critical in asking key questions about the pathogenesis of the organism. This collaborative study with investigators having expertise in Ehrlichia molecular biology and animal studies brings in the needed strength to accomplish the goals set for this innovative research having important implications in moving the Ehrlichia field significantly forward.